Food Insecurity and Diet Quality: Effects on Liver Disease in People with HIV

ABSTRACT
Liver disease is a leading cause of morbidity and mortality among people with HIV (PWH) driven by high rates
of metabolic dysfunction-associated steatotic liver disease. Recently, food insecurity, or the limited or uncertain
availability of nutritionally adequate foods or the inability to acquire acceptable foods in socially acceptable ways,
has emerged as a risk factor for liver disease in people with and without HIV. Women with HIV are particularly
susceptible to food insecurity due to competing demands as caregivers and lack of control over household
resources. We have shown that food insecurity is associated with greater steatohepatitis and liver fibrosis, but
not with steatosis, in PWH, suggesting that factors besides steatosis mediate this association. Our central
hypothesis is that poor diet quality due to food insecurity leads to immune activation, which in the setting of HIV
accelerates steatohepatitis and fibrosis progression. The scientific objective of this proposal is to identify the
mechanisms that underlie the associations between food insecurity, diet quality, and liver disease progression
in PWH. To address these knowledge gaps, we will leverage a robust longitudinal cohort, the Multicenter AIDS
Cohort Study/Women’s Interagency HIV Study Combined Cohort Study (MWCCS), which includes serial food
insecurity measures, comprehensive 24-hour diet quality recall surveys, immune activation biomarkers, and
vibration controlled transient elastography-measured steatohepatitis and fibrosis. The scientific aims are to (1)
examine the association of persistent food insecurity and diet quality with liver disease progression (2) determine
the contribution of immune activation to the association of food insecurity with liver disease and (3) identify
specific dietary factors that influence the relationship of food insecurity and immune activation in people with or
at risk for HIV. This K23 will provide key training in (1) nutrition-specific content expertise and skills in rigorous
diet quality measures, (2) complex biostatistical methods for longitudinal data and mediation analyses, (3)
expertise in measures of immune activation in liver disease and HIV, and (4) career development at the
intersection of hepatology and nutrition, which will be achieved through formal courses, workshops, didactics,
hands-on experience, and structured mentorship. These scientific aims and training goals are made possible by
a rich scientific environment at the University of Southern California, access to a unique prospective multicenter
data set (MWCCS), and a strong multidisciplinary mentorship team consisting of Dr. Terrault (liver disease,
clinical and translational studies), Dr. Goran (nutrition), Dr. Price (HIV and liver disease, immunology), and Dr.
Mack (advanced biostatistics). This research will set the stage for an R01 proposal to develop a dynamic risk
score that incorporates the contribution of diet quality through clinical and immunologic biomarkers to predict
changes in liver disease over time. In summary, the proposed multidisciplinary team, scientific aims, and career
development goals will foster Dr. Kardashian’s transition to a successful independent investigator and guide in
the development of interventions that will halt the progression of liver disease in vulnerable populations.

Public health relevance
PROJECT NARRATIVE Metabolic dysfunction-associated steatotic liver disease is a leading cause of morbidity and mortality in people with and without HIV, and food insecurity, or the limited or uncertain availability of nutritionally adequate foods, is a fundamental driver of greater steatotic liver disease prevalence and poorer health outcomes. This proposal, through the use of a large longitudinal cohort, is designed to investigate the reasons that underlie the association between food insecurity and liver disease in HIV, including the role of diet quality and HIV-associated immune activation. Our findings will contribute to the development of interventions to alleviate food insecurity, a major public health issue, and reduce morbidity and mortality from liver disease in the U.S.